Tobacco Cessation Treatment for Alaska Native Youth

DESCRIPTION (provided by applicant): Tobacco use among adolescents is a major public health problem in the United States. The prevalence of tobacco use among adolescents is currently highest among American Indians and Alaska Natives. Among Alaska Natives residing in the Yukon-Kuskokwim (Y-K) Delta region of western Alaska, approximately 29% of 11-14 year olds, and 63% of 15-18 year olds, use tobacco. No prior work has evaluated tobacco cessation interventions for Alaska Native adolescents. This proposal builds on our successful partnership and 7 year track record of collaboration with the Y-K Delta Alaska Native community. The objective of this proposal is to develop and pilot test a novel, culturally- appropriate, behavioral treatment approach for tobacco cessation among Y-K Delta Alaska Native adolescents ages 12 to 17. The behavioral intervention will include an initial, 2 day, group-based program with follow-up support for 6 weeks. Social cognitive (learning) theory is the conceptual basis for the proposed intervention. We expect that as a result of this stage I project, we will have developed a replicable, feasible, and acceptable intervention, the efficacy of which can be tested in future large-scale randomized clinical trials. This project will take place in two phases. In phase 1, we will develop the intervention with feedback from a teen advisory group, and develop a counselor manual. Follow-up strategies will also be developed, pilot- tested, and refined. Twenty adolescents will complete the protocol, which will be refined in an iterative manner based on feedback from participants and counselors. Phase 2, consisting of a pilot clinical trial, will apply a group-randomized design with assessments at weeks 0 (baseline), 6, and 26. Eight villages will be randomized to receive either the behavioral intervention or control condition (written self-help materials + quit line referral). Ten adolescents will be enrolled from each village, for a total of 80 participants. We will assess the feasibility and acceptability of the intervention, as determined by qualitative ratings of treatment acceptability, and recruitment and retention rates. We will estimate the magnitude of the effect of the intervention compared to the control condition on the biochemically confirmed tobacco abstinence rate at weeks 6 and 26, and estimate the intraclass correlation (ICC). At week 6, we will evaluate the effect of the intervention on changes from baseline on perceived social support, self-efficacy for stopping tobacco use, and other mechanisms of change consistent with our theoretical framework. The overall health related objective is to develop effective treatment programs for Alaska Native youth that will ultimately reduce their risk of tobacco- related disease. PUBLIC HEALTH RELEVANCE: About half of Alaska Native adolescents residing in the Yukon-Kuskokwim (Y-K) Delta region of western Alaska use tobacco. This study proposes to develop a behavioral intervention for tobacco cessation that is culturally appropriate for youth of this region. Developing effective tobacco cessation interventions for Alaska Native youth may ultimately reduce their risk of cancer and other tobacco-related disease.

Public health relevance
Narrative About half of Alaska Native adolescents residing in the Yukon-Kuskokwim (Y-K) Delta region of western Alaska use tobacco. This study proposes to develop a behavioral intervention for tobacco cessation that is culturally appropriate for youth of this region. Developing effective tobacco cessation interventions for Alaska Native youth may ultimately reduce their risk of cancer and other tobacco-related disease.